TO INCREASE FUNDING UNDER TASK ORDER HHSN2710001 FOR TOXICOLOGICAL EVALUATIONS OF POTENTIAL MEDICATIONS, PERIOD OF PERFORMANCE: 09/07/2018- 09/06/2020. NIDA REF. NO. N01DA-18-8939

This research and development contract will support pre-clinical acute and repeat dose toxicology and safety pharmacology studies in rodents, rabbits, dogs, and/or monkeys, which support the development of potential pharmacotherapies (medications) to treat substance use disorders. This contract also will support drug interaction studies in rodents, rabbits, dogs, and/or monkeys to assess the safety of potential medications when administered alone and in combination with abused substances.